From active treatment to long-term cancer survivorship – Understanding how care patterns drive adherence to surveillance and screening guidelines

PROJECT ABSTRACT
Administrative Supplements on Long-term Cancer Survivorship: The number of young adult cancer
survivors continues to grow, yet many face healthcare navigation issues stemming from insurance-related
challenges, financial toxicity and care fragmentation. If unresolved, these issues can lead to loss of follow-up
and inadequate long-term cancer surveillance and screening during the survivorship phase. To address this,
navigation support interventions, such as CHAT-S, a virtual insurance program tested in the parent award
(R01276825), can be deployed as young adult cancer survivors transition to the survivorship phase to maintain
continuity of care. Understanding care patterns during and immediately after primary treatment can assist to
refine the implementation of such interventions to improve long-term survivorship outcomes, including
surveillance for cancer recurrence and screening for second cancers. Therefore, the aim of our proposed
project is to evaluate how care patterns during and immediately after primary treatment may differ between
young adult cancer survivors who received recommended long-term surveillance care and screening for
second cancers starting 5 years after diagnosis and those who did not. Specifically, we will examine two types
of care patterns: (i) how young adult cancer patients engage the healthcare system while receiving treatment
(care engagement patterns) (Specific Aim 1) and (ii) how care management is structured as young adult
cancer patients transition to the survivorship phase (care management patterns) (Specific Aim 2). To do this,
we will leverage a statewide longitudinal cohort of 6,600 young adult cancer survivors with data linkages to
statewide hospitalization, emergency department, and claims data. Care engagement patterns will be identified
using a latent profile analysis of healthcare resource utilization indicators during active treatment, namely
treatment non-adherence, emergency/urgent care use and unplanned hospitalizations. Care management
patterns will be assessed using social network analysis metrics, which are primarily measured based on
shared patients between provider pairs and represent care coordination and communication within each
patient’s clinical care team. The association of both types of care patterns and receipt of recommended long-
term surveillance care and screening for second cancers will be then evaluated using multivariable logistic
regression. Proposed work under this supplement builds on the parent award (R01276825) as our findings will
identify patient subgroups that will benefit the most from CHAT-S and inform future iterations of the
intervention. In the long term, this proposed research will guide the development of other navigation support
tools that will improve adherence and facilitate transition of care among young adult cancer survivors. Given
the study team’s analytical expertise and existing access to the required dataset, the proposed work is feasible
to complete within the 1-year supplement period.

Public health relevance
PROJECT NARRATIVE Young adult cancer survivors face challenges navigating the healthcare system, which can hamper them from receiving follow-up care and detecting cancer recurrence or second cancers early. Our research will study how young adult cancer patients engage with the healthcare system and receive care during and after treatment to identify patterns that can predict or affect their chances of receiving recommended long-term cancer surveillance and screening. Findings from our project will improve the design and delivery of programs that ensure young adult cancer survivors stay connected to get and receive the follow-up they require.